Investigating dysregulation of hematopoietic stem cell support in sickle cell disease mesenchymal stromal cells

Project Summary
Sickle cell disease (SCD) is one of the most common hemoglobinopathies in the world. It results from a mutation in the
hemoglobin β gene which causes hemoglobin polymerization, leading to chronic hemolysis, inflammation, damage to
organs, and increased early morbidity. SCD pathophysiology can damage and stress the bone marrow microenvironment
and resident hematopoietic stem cells (HSCs), as evidenced in our pilot studies revealing fewer functional HSCs in the bone
marrow of both mice and individuals with SCD. Sinusoidal and arterial vascular networks in the SCD bone marrow are also
significantly disrupted. Furthermore, SCD is marked by decreased numbers of mesenchymal stromal cells (MSCs), a
heterogeneous cell population that functions as critical regulators of HSC self-renewal and differentiation. We observed
significant changes to MSC transcriptional profiles in SCD and identified three aberrant SCD MSC phenotypes: 1) increased
SCD MSC cell cycling, 2) increased secretion of inflammatory cytokines, and 3) decreased HSC support. The transcription
factor Early B Cell Factor 3 (EBF3) is a standout differentially expressed gene in SCD MSCs and a known regulator of cell
cycle. Loss of EBF3 in MSC subpopulations dramatically impacts bone marrow composition and HSC support. Cumulatively,
these findings lead me to hypothesize that EBF3 downregulation in bone marrow MSCs during SCD causes
transcriptional changes that decrease their HSC support capacity. In Aim 1, I will determine how Ebf3 downregulation is
driving the changes we observe in mouse SCD MSCs via over-expression and knockdown of Ebf3 in SCD and control MSCs;
I will then quantify changes to their HSC support capacity through ex vivo primary cultures and in vivo transplantation
studies. In Aim 2, I will identify EBF3 transcriptional targets and their cellular functions in control and SCD MSCs via protein-
chromatin interaction studies, gene ontology analysis, and gene set enrichment analysis as well as mechanistic
interrogation of Ebf3 downregulation. In Aim 3, I will investigate the translational impact of EBF3 downregulation in human
SCD MSCs by again employing over-expression and knockdown systems to perturb EBF3 expression and quantify how this
impacts their support of human HSCs. I will also elucidate the transcriptional targets of EBF3 in human MSCs, which has
never been done before. This study will be an important first step in better understanding how transcriptional dysfunction
in SCD MSCs influences HSC support, which, in turn, may be critical in the improvement of SCD curative therapies.

Public health relevance
PROJECT NARRATIVE Sickle Cell Disease (SCD) is a painful inherited blood disorder with significant early mortality that affects millions of people worldwide. Hematopoietic stem cell (HSC) transplantation remains the only curative therapy; however, little is known about how the HSC bone marrow niche health could be impacting transplantation recovery and success, and how damage to the bone marrow niche by SCD pathophysiology contributes to post-transplant complications. This work will be an important first step to understanding how transcriptional dysfunction in SCD MSCs influences HSC support, which could ultimately have implications for improved success of SCD curative therapies.